Peptide regulation of mosquito blood feeding and mating

Project Summary
Mosquitoes are obligate blood-feeders that pose increasing threats to global public
health by spreading the pathogens that cause diseases, including Zika and malaria, among
humans. Blood-feeding and mating behaviors play key roles in vector biology and undergo
dramatic changes influenced by environmental cues and internal state but we know little about
the physiological changes underlying the behavioral readout. Neuropeptide signaling pathways
are ancient and conserved regulators of feeding and reproduction in many animals, including
mosquitoes. The long-term objectives of this research are to define the mechanisms by which
neuropeptide signaling coordinates organismal physiology in mosquitoes to regulate blood-
feeding and reproduction. Building on recent breakthroughs that have allowed us to genetically
disrupt critical neuropeptide pathways and manipulate the cells that express these genes, we
will use an innovative combination of pharmacological and genetic techniques to ask how
specific neuropeptides coordinate organismal physiology to coordinate these innate behaviors.
The drive to blood feed is not constitutive; female mosquitoes suppress their drive to bite
humans at specific times of day, during blood digestion, and egg development. Although it is
clear that nutrient sensing, oocyte development, and circadian signals influence each other,
exactly how these individual components combine to temporally regulate mosquito attraction to
humans remains unknown. We will determine how cellular responses and behavioral features of
host-seeking are regulated by circadian and satiety-related neuropeptide pathways.
Mating and reproductive behaviors also show variation by time of day and female
physiological state. Female mating receptivity is regulated by signals, including neuropeptides,
that are transferred from males to females during mating. These signals suppress female
receptivity for the rest of her lifetime and allow her to allocate nutritional resources for
reproduction. We will ask how neuronal, physiological, and behavioral responses to mating
signals change by time of day and female mating status and determine how neuropeptides
control these responses by evaluating females with disrupted circadian and mating-related
neuropeptide signaling pathways.
These results will provide the basis for novel approaches to mosquito control since
targeting the receptors that affect biting and reproduction could be “weaponized” against
mosquitoes to disrupt these behaviors.

Public health relevance
Project Narrative Female mosquitoes spread pathogens by biting humans to feed on their blood and using the protein from these meals to develop eggs and reproduce. This research project will characterize critical neuropeptide signaling pathways that underlie the physiological changes that control blood-feeding and reproduction. These results will inform new strategies to prevent the spread of illnesses including Zika, dengue fever, and chikungunya by directly targeting the pathways that contribute to the spread of mosquito-borne disease.